Genes underlying reproductive behavior physiology and neuronal development

Project Summary/Abstract
To understand mental health and disease, we need to understand the function of the brain at the level
of genes, gene regulatory networks, neurons, circuit structure, and physiology. Drosophila has
emerged as one of the most powerful model systems for these questions, given the range of tools and
the tractability of analyzing complex behaviors at all these levels. This proposal seeks to understand
Drosophila reproductive behaviors. One reason Drosophila is such a powerful system is that the sex-
specific master regulatory transcription factors that direct reproductive behaviors are known. This has
provided a powerful molecular inroad into identifying and manipulating the neurons that underlie these
behaviors. These tools can also be used to perform neuron-specific mutational studies to discover the
functions of genes that direct behaviors, which leverages one of the biggest strengths of the Drosophila
model system. In addition, this system affords an unparalleled model to both examine the sex-specific
development of these neurons and how they are modified by adult experiences. Research using the
Drosophila model has continued to uncover biologically important processes that have informed on
human health and disease, including studies of the nervous system and behavior. The work will build
off of my laboratories 15-year NIGMS funded research program. We will continue to address these
behavioral questions using cutting-edge molecular-genetic, genomic, proteomic, behavioral and
microscopy tools to gain insights into complex behaviors.

Public health relevance
Project Narrative Understanding human mental health disorders requires a basic understanding of the nervous system. It is critical to understand how neuronal connections are built during development and how neural circuits function in the adult. This study seeks to understand at a molecular-genetic level how the potential for behavior is built into the nervous system. These studies will proceed with analyses in a multi-cellular organism, so we can interrogate the role of genes, proteins and neural circuits in a functionally relevant context to gain insight in how a circuit for a complex behavior is built and functions.